Pfn1’s Role in Genomic Stability and Immune Response in Breast Cancer

Project Summary
Breast cancer is the second leading cause of cancer related deaths in women in the United States Immune
checkpoint blockade immunotherapy is an emerging treatment for breast cancer, particularly for triple-negative
breast cancer which lacks targeted therapies. Immune checkpoint blockade failure is often due to immune-
excluded tumor microenvironments, specifically the absence of CD8+ T cell infiltration. Currently immune
checkpoint blockade agents are used in combination with conventional chemotherapies which enhance the
function of immunotherapy by inducing DNA damage a trigger for an anti-tumor immunological response.
However, tumors are known to become resistant to chemotherapies, therefore identification of novel
mechanisms to induce DNA damage and thus CD8+ T cell infiltration is key for improving immune checkpoint
blockade immunotherapy success.
Profilin-1 (Pfn1) is an actin-binding protein that has been reported to have context dependent tumor intrinsic
roles in breast cancer. While overexpression of Pfn1 has been shown to suppress tumorigenesis, knockdown of
Pfn1 has been demonstrated to limit metastatic outgrowth. However, the impact of Pfn1 modulation on the tumor
immune microenvironment in breast cancer remains uninvestigated. My preliminary data suggests genetic
disruption of the Pfn1 gene leads to an increase in CD8+ T cell infiltration and significant tumor regression. The
goal of this project is to investigate whether and how loss of Pfn1 causes a pro-inflammatory, anti-tumor
microenvironment thereby increasing immunotherapy efficacy.
The proposed research will be complemented by a training plan I designed to achieve the aims of this project
and prepare myself for the next phase of my research career. My undergraduate and early graduate school
research focused on molecular mechanisms of cancer cell migration and tumor biology. During the F31
fellowship period I will extend my understanding of cancer to the tumor immune microenvironment and
immunotherapy treatment. I will learn technical skills including how to perform flow cytometry analysis,
immunotherapy administration, and microfluidic device fabrication. I will build upon my skills in the design of
rigorous scientific approaches, mentorship, and outreach.

Public health relevance
PROJECT NARRATIVE Immune checkpoint blockade immunotherapy is a promising treatment for breast cancer patients, most critically for triple-negative breast cancer patients who have the worst overall prognosis given the lack of targeted therapies. The goal of this project is to determine whether and how genetic disruption of the gene encoding Profilin-1, an actin-binding protein, promotes the existence of an anti-tumor immune environment, thus increasing the efficacy of immunotherapy. If successful, the completion of these studies will elucidate a novel mechanistic link between Pfn1 loss and an anti-tumor immune response and lay the conceptual foundation for the inhibition of Pfn1 as a therapeutic supplement to immunotherapy.